ABCD-USA Consortium: Coordinating Center

PROJECT SUMMARY
In its initial funding period, the ABCD consortium used a rigorous epidemiological approach to recruit a diverse
sample of 11,878 9- to 10-year-olds through our 21 research sites, of which 2,136 are twins or triplets. Expert
workgroups (WGs) designed protocols using proven methods to assess, scan, and maintain this cohort with very
high retention rates. The study complements well validated standardized assessments with novel real-time
objective data collected wirelessly in the natural environment to securely capture indices of youth behaviors.
These technologies add measurement precision, ecological validity, and an opportunity to reveal previously
unknown effects of behavioral, physiological, and environmental factors in the development and fluctuation of
substance use, screen media use, mental and physical health concerns, brain development, and their dynamic
relationships. Bioassays (e.g., from hair, shed teeth, blood, and oral fluid) provide genome-wide genotyping,
pubertal hormones, more precise estimates of exposures to substances of abuse and environmental toxins, and
eventually more comprehensive estimates of relevant epigenetic effects. State-of-the-art harmonization methods
for MRI and other data enable seamless data integration across sites into an invaluable open-science database
that becomes available to the larger scientific community within a year of data collection. The Coordinating
Center (CC) met all of its previous aims, and here describes how it will achieve an adjusted set of aims for the
next 7 years. Specifically, we describe a flexible organizational framework created for management of the study
that relies heavily on cross-disciplinary knowledge and extensive research experience of expert assessment
WGs and strategic planning groups, and a dedicated team within the CC, Data Analysis, Informatics and
Resource Center (DAIRC), and NIH to coordinate internal and external communications; support and integrate
the development and revision of protocols and data quality reviews performed by WGs; establish, monitor, and
maintain the standardization of study protocols across the consortium sites; measure and review study progress
toward goals for retention, data quality, and scientific impact; based on these metrics, take supportive and
corrective action to ensure that the goals are met; manage bioethics policies and consortium interactions with
the single IRB (sIRB); promote the professional development of diverse junior investigators; establish a
framework to resolve conflicts within the CC or within the wider consortium; and responsibly address any
unanticipated scientific, methodological, logistical, or ethical challenges to ensure the study achieves its
overarching objectives. We also describe how the CC and DAIRC will together implement quality control
procedures to improve data quality across all data types; coordinate data sharing functions with the staff of the
NIMH Data Archive; manage a pipeline for enhancing the study with novel assessment technologies; and
facilitate rigorous analyses of ABCD data that set new standards for use of data from this powerful, but complex
and challenging, high-dimensional study.

Public health relevance
PROJECT NARRATIVE The landmark Adolescent Brain Cognitive Development (ABCD) Study is following over 11,800 children beginning at 9 and 10 years of age in 21 U.S. communities. Over the next 7 years, the study aims to provide critical information about what factors present during their adolescent and young adult years may either strengthen their development or place them at higher risk of poor mental, physical, or behavioral health.